Molecular mechanism of hypertrophic cardiomyopathy in populations of South Asian descendants

? DESCRIPTION (provided by applicant): Cardiac myosin binding protein-C (cMyBP-C) is a heart-specific muscle protein that regulates cardiac structure and function. Mutations in the cMyBP-C gene are a leading cause of hypertrophic cardiomyopathy (HCM). Previously, we discovered and described a variant in the cMyBP-C gene (MYBPC3) that leads to a change in the C10 domain of the C'-region (cMyBP-CΔC10) and is associated with the development of HCM and heart failure (HF). It has been estimated that cMyBP-CΔC10 is inherited in ~60 million South Asians, who have a statistically higher risk of heart disease and higher mortality rate after myocardial infarction. However, the molecular mechanism underlying the pathogenicity of cMyBP-CΔC10 is unknown. Therefore, our short-term goal is to define the pathogenic mechanism that leads to HCM via this genetic route and develop therapeutic strategies to treat it. Our long-term goal is to determine the molecular mechanisms underlying the pathophysiology of MYBPC3 mutations in relation to the etiology of HCM to provide a foundation for developing novel therapies. To those ends, the overall objectives are to (1) determine whether cMyBP-CΔC10 plays a pathogenic role in the etiology of HCM by using a transgenic mouse model; (2) define whether activation of the protein kinase R-like ER kinase (PERK) pathway, one of the unfolded protein responses, is the molecular mechanism underlying cMyBP-CΔC10 pathogenicity; and (3) determine whether expression of cMyBP-CΔC10 further exacerbates ischemia-reperfusion injury and, if so, whether inhibition of the PERK pathway is cardioprotective. Our central hypothesis is that cMyBP-CΔC10 causes HCM by inducing the PERK pathway, further aggravating IR injury and increasing morbidity and mortality. To test this hypothesis, a cardiac-specific transgenic mouse model expressing cMyBP-CΔC10 in the heart has been established. It will be used to study the disease mechanism and to evaluate potential therapeutic targets. Pilot studies show that transgenic lines with 50% cMyBP-CΔC10 expression, compared to endogenous cMyBP-C, show the HCM phenotype by 12 weeks of age, suggesting that cMyBP-CΔC10 is sufficient to recapitulate the human HCM disease phenotype. Using these mice, SPECIFIC AIM 1 will precisely determine the pathological consequences of cMyBP-CΔC10 on cellular and whole-organ function. SPECIFIC AIM 2 will use pharmacologic and genetic approaches to determine whether inhibition of PERK can prevent and/or rescue the development of the HCM phenotype in cMyBP-CΔC10 mice. SPECIFIC AIM 3 will determine whether cMyBP-CΔC10 expression is a risk factor for increased morbidity and mortality after IR injury. PERK inhibition will be tested for its ability to rescue the HCM phenotype and reduce the pathogenic consequences of IR injury.

Public health relevance
PUBLIC HEALTH RELEVANCE: The long-term objective is to understand the pathogenesis of a MYBPC3 genetic variant known to cause hypertrophic cardiomyopathy (HCM) in approximately 60 million South Asian descendants. In particular, the proposed studies will determine the molecular mechanism underlying the pathogenicity of this mutation, leading to the discovery of cardioprotective agents to prevent or ameliorate HCM and heart failure.